Training in Developmental Biology

DESCRIPTION (provided by applicant): This application from Oregon Health & Science University will establish a new training program in Developmental Biology. The goal will be to train physicians and scientists to become leaders in research in the physiologic and molecular basis of development. OHSU will provide a comprehensive educational program, protected time for research training, and a strong environment for academic development. The program will be in partnership with one of the following training opportunities: Medical Genetics, Metabolism, NeonataI-Perinatal Medicine, Pediatric Cardiology, Pediatric Critical Care, Pediatric Endocrinology, Pediatric Hematology/Oncology, Pediatric Nephrology, Pediatric Neurodevelopmental Disabilities, Pediatric Pulmonology, and the joint Program in Molecular and Cellular Biosciences. The Program Director is De-Ann M. Pillers, MDPhD, who also serves as Program Director of the NICHD Oregon Child Health Research Center. Dr. Pillers will be supported by an Advisory Committee consisting of OHSU scientists with an international reputation in developmental biology: John M. Bissonette, MD, Ron G. Rosenfeld, MD, and Kent Thornburg, PhD. The Program Faculty consists of senior members of the OHSU research community who have stable NIH support and a track record of successful trainees. External review of the program will be provided by three renowned scientists in developmental biology: Alan H. Jobe, MDPhD at Cincinnati Children's Hospital, Edward R.B. McCabe, MDPhD, Executive Chair of Pediatrics at UCLA, and Charles R. Rosenfeld, MD, at the University of Texas, Southwestern in Dallas. Funding of the program will expand fellowship positions by two per year, with the additional support of one predoctoral basic science graduate student, and two medical student positions. Fellows who complete this program will have outstanding opportunities to join the faculty at OHSU for continued academic development as laboratory-based Junior Investigators of the NICHD Oregon Child Health Research Center.